MicroRNA-based therapy for rheumatoid arthritis

PROJECT SUMMARY
MicroRNAs (miRNAs) are single stranded non-coding RNAs that have emerged as a novel posttranscriptional
regulators in rheumatoid arthritis (RA) pathogenesis. However, recent studies provide evidence that in general there
is an overall reduction in miRNA expression in disease states such as cancer and RA. While the rationale for
developing miRNA therapeutics are conceptually similar to other inhibitory approaches, restoring the function of a
miRNA by miRNA replacement is a less characterized, yet potential therapeutic option never tested in RA. Intriguingly,
the underlying reasons for disrupted miRNA biogenesis and degradation processes in RA are not fully understood.
Our recent finding provides evidence that miR-17 expression was significantly low in RA serum, synovial fibroblasts
(SFs), and synovial tissues (STs), as well as in the serum and joints of adjuvant-induced (AIA) rats. RNA-sequencing
analysis showed modulation of 664 genes by the restoration of miR-17 levels using precursor (pre)-miR-17 in human
RASFs. Ingenuity pathway analysis of RNA-sequencing data identified the ubiquitin proteasome system in the TNF-α
signaling pathway as a primary target of miR-17. Furthermore, the restoration of miR-17 levels using precursor-miR-
17 (pre-miR-17) reduced the ability of ubiquitin E3 ligase TRAF2 to associate with its signaling partner, cIAP2, thereby
inhibiting TNF-α-induced downstream signal transduction pathways and suppressing the production of IL-6, IL-8,
MMP-1, and MMP-13 in human RASFs. While these novel findings provide evidence for the impact of miR-17
replacement on posttranslational processes critical in TNF-α signaling in RASFs, several questions important to miR-
17 biogenesis and turnover remains unanswered, including the reasons for severely low expression in RA, the impact
of proinflammatory cytokines on miR-17 biogenesis and turnover, and the relevance and efficacy of miR-17
replacement therapy in RA. Based on these novel observations, we propose that miR-17 replacement therapy could
ameliorate RA. Thus, in specific aim 1, we will determine the deregulated mechanism of miR-17 biogenesis and
turnover in RA. In aim 2, we will evaluate the relevance and molecular mechanisms of miR-17 restoration on TNF-α-
induced molecular and phenotypic changes in human RASFs. Finally, aim 3 will test the in vivo efficacy of miR-17
delivery in TNF-α transgenic (hTNF-tg) mouse model and rat AIA model of human RA. The success of these studies
will lead to two clinically distinct findings: 1) Elucidation of the altered miRNA biogenesis and turnover mechanism in
RA pathogenesis, and 2) the validation of miRNA-based therapeutic approaches for the treatment of RA.

Public health relevance
PROJECT NARRATIVE MicroRNA-based therapies are emerging as the potential next-generation therapeutics for a variety of diseases, including rheumatoid arthritis (RA). Hence, it is important to fully understand the molecular mechanisms of deregulated miRNA expression in RA. The lack of such knowledge in human RA synovial fibroblast (RASF), an important cell-type known to play an important role in local inflammation and tissue destruction in RA, has limited our ability to test miRNA therapeutics. The success of the proposed studies will uncover the epigenetics and transcriptional mechanisms that cause deregulated miR-17 biogenesis and degradation in RA, and will provide the relevance of miR-17 restoration through pre-miR-17 delivery as a potential therapeutic strategy in the treatment of RA.